Biostatistics Core

DM&SC Abstract
The Study on Interactions between SARS-CoV-2 infection and Ancestral genomic Variations in the Risk of
Alzheimer’s Disease (ISAVRAD) is an international, multi-site study to characterize individuals from ancestral
populations, including Amerindians from the Andes mountains and Africans from Nigeria, as well as from
individuals with variable admixture from Southern Texas (Mexican Americans), Seattle (no-tribal Native
Americans) and the Bronx (Hispanic/Latinos and African Americans) using a uniform protocol. Characterization
at baseline includes descriptions of the COVID-19 disease severity, vaccination status, date of documented
infection and identity of the prevalent virus variant at each site at the time of infection and whole genome
sequencing, as well as deep phenotyping and longitudinal follow up of neurological, cognitive and
neuroimaging signatures that may detect cognitive decline or dementia as long-term sequelae of the SARS-
CoV-2 infection. The Data Management and Statistics Core (DM&SC) is one of 4 Cores supporting the
scientific research activities of the four ISAVRAD Program Projects and is responsible for management,
reporting and sharing of raw and meta-data generated by the Clinical and Neuroimaging Cores; from NIA
ADSP components (NCRAD, NIAGADS and GCAD); and from ISAVRAD Projects, to allow completion of the
proposed aims and foster collaboration within and outside the ISVRAD network. Led by the two Informatics
and Statistics Core leaders for the South Texas Alzheimer’s Center, the DM&SC is equipped with advanced
informatics, data management, and statistical infrastructure and expertise to meet these specialized needs.
Drs Zozus and Sanns boast decades of experience providing comprehensive coordinating center support for
clinical studies and offer extensive practical knowledge of regulatory-grade data handling requirements and
methods. Drs. Wang and Himali provide design and analysis expertise. The DM&SC will provide reliable
processes for the recording, management, storing and sharing of data and metadata within and outside the
ISAVRAD network to support the mission of the other cores and foster the completion of the Projects aims and
collaborative efforts, with the goals of aligning ISAVRAD data with appropriate standards to maximize data
reuse (Aim 1); providing information systems and expert support for data and sample collection and
management (Aim 2); and urating and preparing data for external sharing through national repositories.